Contribution of novel lysoplasmalogenases enzymes in regulating macrophage immunometabolic responses in cardiovascular disease

PROJECT SUMMARY
Alterations in the control of lipid homeostasis can lead to cardiometabolic diseases, including
atherosclerosis, the most common cause of mortality in Western societies.
Our previous studies have demonstrated the importance of miRNAs in regulating high-density
lipoprotein (HDL)-C and LDL-C. Work from our group and others identified miR-33a/b as key regulators of
cellular cholesterol efflux and uptake, HDL biogenesis and fatty acid metabolism. Notably, we have recently
discovered that miR-33 and the nuclear receptor liver X receptor (LXR) regulates the expression of
transmembrane protein 86a (TMEM86a), which is a lysoplasmalogenase that regulates plasmalogen
(phospholipid) metabolism. This finding is highly relevant given the key role of these phospholipids as
reservoir of polyunsaturated fatty acids, which are the precursors of bioactive lipids that control inflammation
resolution. Plasmalogen/lysoplasmalogen content in cells can also regulate membrane fluidity, which may
contribute to cytokine-mediated inflammatory responses, efferocytotic capacity, ER stress, lipid
peroxidation, and cellular cholesterol efflux in macrophages. Notably, TMEM86a is highly expressed in
human and mouse atherosclerotic lesions, suggesting a relevant role for this enzyme in regulating
macrophage immunometabolic response during atherosclerosis.
Together, these novel findings strongly suggest that LXR/miR-33/TMEM86a signalling pathway
might contribute to the chronic vascular inflammation observed in atherosclerotic lesions. To investigate the
functional relevance of TMEM86a in regulating macrophage phospholipid metabolism during the
progression of atherosclerosis, we have recently generated a mouse model that lack the expression of
TMEM86a in macrophages. Using these mice and cutting-edge techniques (genomics and metabolomics),
we will elucidate the contribution of LXR/miR-33/TMEM86a pathway in atherogenesis.

Public health relevance
PROJECT NARRATIVE Atherosclerosis underlies the leading cause of death in industrialized societies. During atherogenesis, the accumulation of apolipoprotein B containing lipoproteins (LDL and VLDL) in the matrix beneath the endothelial layer of blood vessels leads to the recruitment of monocytes, cells of the immune system that give rise to macrophages and dendritic cells. Macrophages derived from recruited monocytes participate in a maladaptive non-resolving inflammatory response that expands the subendothelial layer due to the accumulation of cells, lipids, and matrix. This proposal aims to investigate the contribution of TMEM86 enzymes in regulating phospholipid remodeling and plasmalogen-derived active lipids mediators in macrophages. We will define how plasmalogen metabolism regulated by TMEM86a controls macrophage immunometabolic responses during the progression of atherosclerosis.